Interhemispheric coordination and transfer of visual information

Abstract
It has been a tacit assumption that the “split” of visual sensory processing between right vs left visual
hemifields (between the left vs right visual cortex, respectively) is somehow “healed” in higher cortex/
cognition. We now know that is not true, at least not in any straightforward way. Yet visual cognition seems
seamless, not split down the middle. We don’t know how it becomes seamless because neurophysiology
experiments typically study only one hemisphere at a time. Our project uses bilateral multiple-electrode
recordings to test hypotheses about how visual information is coordinated and transferred between cerebral
hemispheres. Monkeys will perform tasks in which information is transferred between hemispheres by gaze
shifts, by a moving object’s trajectory, or in which information is loaded simultaneously into both hemispheres.
Our results will give insights into the neural basis of visual cognition, consciousness, and into cortical
communication in general. This is especially relevant for understanding disorders of interhemispheric
interaction, such as dyslexia and hemispatial neglect.

Public health relevance
Narrative Visual processing in the cortex is “split” between right vs left visual hemifields yet visual cognition seems seamless, not split down the middle. Our project uses bilateral multiple-electrode recordings to test hypotheses about how the cerebral hemispheres function together and “heal” this split. Our results will give insights into the neural basis of visual cognition and into disorders of interhemispheric interaction, such as dyslexia and hemispatial neglect.